Occupational Safety and Health Program Improvement

With over forty years of experience in educating Occupational Safety and Health (OSH)
students, the purpose of this proposal is to strengthen the learning environment to prepare the
next generation of leaders in OSH practice. This will be accomplished by preparing graduate
students who are well-trained to enter the workforce, ready to respond to both established risks,
as well as new challenges brought on by the changing nature of work. The primary focus will be:
1. Opportunities for interaction between faculty internship instructors and on-site intern
supervisors to sustain and advance employer-intern-university relationships.
2. Develop and host workshops and seminars to address advances in OSH practice.
3. Faculty professional development to respond to the changing nature of work.
4. Support for graduate students in the form of tuition, fees, and travel.
5. Improve program curriculum to modernize offerings.
6. Increase program's capacity for use of virtual/digital applications in placement-related
activities, communication, academic offerings, and profession-related applications.
The OSH department had 289 students in the program during the fall 2019 semester which
included 39 in the graduate program and 250 in the undergraduate program.

Public health relevance
The Department of Occupational Safety and Health at Murray State University supplies diversified education and training for occupational safety and health professionals to meet the local, regional, and national demand. Curricula, programs, and training within the department are designed to meet the professional preparation of students as well as the manpower, continuing education, training, and advisory needs of the region and state.